Evaluating and Improving Utilization of Evidence-Based Medical Therapy in Patients with Heart Failure using Automated Tools in the Electronic Health Record

PROJECT SUMMARY
Heart failure (HF) affects over 6 million US adults, with high rates of hospitalization and nearly 50% mortality at
5 years from diagnosis. Nearly half of these patients have systolic HF with multiple evidence-based therapeutic
options proven to reduce the risk of hospitalization and mortality in this subgroup of patients. Evaluating the
appropriate utilization of these therapies is currently limited to post-hoc assessments of manually abstracted
patient records at a limited number of hospitals participating in quality improvement registries. These manual
abstraction strategies do not offer opportunities to improve care in real-time, and even at hospitals engaged in
quality improvement efforts, only 1 in 5 of eligible patients with HF receive all first-line evidence based medical
treatments. In this patient-oriented mentored career development award proposal, Dr. Rohan Khera proposes to
leverage the ubiquitous digitization of medical records in the electronic health record (EHR) to address the
adequate utilization of evidence based medical therapy in HF. He proposes to use a large, publicly accessible,
deidentified EHR database to develop and validate an algorithm that uses deep learning based natural language
processing (NLP) within unstructured clinical documentation for hospitalized HF patients to identify those with
systolic HF (Aim #1). He will engage clinicians to design consensus-based algorithms to identify
contraindications to HF treatments, developed as algorithms within the EHR (Aim #2). Finally, he will construct
a prototypic clinical decision support (CDS) tool identifying HF treatment eligibility in real-time using the
algorithms and evaluate potential implementation strategies using qualitative evaluation of feedback from
clinicians and patients (Aim #3). While proposed as a strategy to evaluate quality of care of individual patients,
the proposed research will also model a fully automated electronic clinical quality measure for HF. The algorithms
will be made open source to allow institutions to validate and apply them to their individual care setting. The
proposal is supported by strong mentorship from experts in quality measure design, informatics, advanced NLP,
CDS design, and qualitative research methodology. The facilities at Yale Center of Outcomes Research and
Evaluation, which designs and evaluates national quality measures, and has access to computational resources
required to accomplish the research goals as well as to the Yale EHR to validate the models are major strengths
of the application. The proposed period of mentored research will support Dr. Khera’s training in medical
informatics, advanced analytic tools such as NLP, and qualitative research methodology. The experience and
skillset acquired during this period will support Dr. Khera’s transition to independence where he plans to lead
multi-institutional collaboratives to evaluate the use of automated tools in the measurement and improvement of
the quality of medical care in HF. The career development plan that accompanies the proposal is designed to
support Dr. Khera’s long-term career goal to be a national leader in the design and implementation of informatics-
based approaches of delivering high quality, patient-centered, cardiovascular care.

Public health relevance
PROJECT NARRATIVE The scope of quality improvement programs that focus on improving the utilization of first-line evidence-based medical therapies in patients with heart failure is limited by mechanisms to identify those who are eligible for specific treatments. The current proposal aims to design automated tools to identify patients eligible for heart failure therapies using various data components already captured in the electronic health record in hospitalized patients. The proposal will then pilot test strategies of improving treatment utilization with electronic alerts delivered to clinicians based on these tools.